Community Responsive Project

SUMMARY – COMMUNITY RESPONSIVE PROJECTS PROGRAM
Although academics are well-meaning in designing studies they believe will improve health equity, they often
do not have relevant lived experience to select study questions or study designs; as a result, the research does
not always address priorities for those facing health inequities. We will tackle this challenge by creating a
Center that is embedded in the communities in which the research is conducted and by partnering with
community-engaged researchers from underrepresented backgrounds as key Center leaders.
The goal of the Community Responsive Project (CRP) Program is to create a mechanism to identify
community priorities in cancer control research, and to enable academic and community teams to pursue those
ideas. Our Cancer Center's Community Outreach and Engagement Program has allocated $250K in support
for the CRP Program, which will increase our ability to advance strong CRP ideas. We will also support
academic-community teams to apply for other funding. This approach will help to sustain the concept of
community-responsive research beyond the U19 funding cycle. We have created multiple and interacting
mechanisms for generating ideas for the CRP Program, and an academic-community partnered review
process that ensures strong representation of community perspectives.
Our initial CRP, Using Community Advisory Boards (CAB) to Build and Sustain CHC-Community
Connections (CHC CAB study) will build on community input, our prior collaborative work, the Center's
theme, and the Community Gateway to Health Equity Study, our social determinants of health SDOH project.
The project will test the impact of a community health center- (CHC) based community advisory board (CHC
CAB) Toolkit and implementation support to increase clinic-community linkages. The goals are to: (1) support
the ability of CHCs to gather community and patient input, (2) center the community voice in both the
implementation of the Gateway Study and the CRP project; and (3) increase engagement with local community
partners and residents on cancer prevention and control. The ultimate goal is to build community voice into the
fabric of CHC preventive care decision-making, creating a mechanism for gathering community input about
cancer control priorities and programs and to build supporting community connections. Creating CABs focused
on SDOH and equity in cancer control will bring to light new opportunities and needs that can be channeled
into the CRP Program and integrated into the long-term planning at each CHC.
The CRP Program has been designed to maximize synergy across the Center's components, leverage the
benefits of academic-community partnership, and build capacity of community members to engage in cancer
control equity research participation and review.